The role of platelets in the pathogenesis of alcohol-associated liver disease

Abstract
Mortality due to cirrhosis in the United States is increasing, driven by alcohol-associated liver disease
(ALD). There is currently no specific pharmacotherapy that affects outcomes of ALD beyond short-term
mortality, so new therapeutic targets are urgently needed. Platelets and intrahepatic microvascular thrombosis
are increasingly recognized as key drivers of crucial biological processes within the liver, including liver
fibrosis, portal hypertension, acute liver injury, and liver regeneration, in a highly context-specific manner.
However, our current understanding of the mechanistic role of platelets in liver disease is greatly limited, as
evidenced by the contradictory results of published studies. Platelets interact closely with liver endothelial cells
to coordinate inflammation within the liver, and proinflammatory liver sinusoidal endothelial cells (LSECs) play
a critical role in liver inflammation and fibrosis. In addition to its effects on the liver, alcohol also has direct
pathological effects on the bone marrow and platelets themselves. The goal of this study is to define the role of
platelets in the pathogenesis of ALD.
We have three aims for the proposed research: 1) Define the mechanism of platelet dysfunction in
alcohol-associated hepatitis; 2) Define the pathological effect of platelets in alcohol-associated hepatitis on
LSECs; 3) Determine the pathological role of platelets and platelet-derived microparticles in alcohol-associated
hepatitis in vivo. Our studies will begin in patients, defining specific molecular mechanisms of platelet
dysfunction in alcohol-associated hepatitis using a biochemical, imaging, and bioinformatics approach. We will
then utilize patient samples to determine mechanisms of pathological platelet-LSEC communication resulting in
endothelial inflammation. Finally, we will utilize a preclinical model of alcohol-associated hepatitis to determine
the therapeutic effect of blocking specific mechanisms of platelet-endothelial interaction in vivo
This project will be conducted with the guidance and mentorship of Dr. Yasuko Iwakiri, an expert in liver
vascular biology, and with co-mentorship by Dr. John Hwa, an expert in platelet biology. The project will take
full advantage of the significant material, clinical, and educational resources available within the Yale Liver
Center and Yale University. The goal of this project is to illuminate a new paradigm of pathogenesis in alcohol-
associated liver disease, forming the basis of an independent research career.

Public health relevance
Project Narrative Alcohol-associated liver disease is a pressing public health problem and accounts for increasing mortality due to cirrhosis in the United States. Effective and safe treatments for alcohol-associated liver disease are severely lacking. This project proposes a new paradigm of pathogenesis in alcohol-associated liver disease with the possibility for novel therapies.